Development of a Novel Biomarker and PET Radiotracer for Specific Imaging of Microglial Responses

Project Summary/Abstract
Chronic microglial activation is an early and critical driver of neurodegenerative diseases. Hence, there is an
urgent need to measure microglial responses in vivo. Positron emission tomography (PET) provides a non-
invasive means to track and quantify microglial responses. However, current approaches are limited by the lack
of microglial-specific imaging biomarkers. To address this gap, we propose the development of the first Tandem
pore domain halothane-inhibited K+ channel 1 (THIK-1)-targeted PET radioligands. THIK-1 is a K+ channel which
exhibits high microglial specificity. Moreover, THIK-1 was recently associated with microglial functions such as
proinflammatory IL-1b release and phagocytosis and identified as a therapeutic target for neurodegenerative
diseases. We have identified two lead small molecule candidates as the first THIK-1-targeted PET probes,
exhibiting THIK-1 specificity and high potential to cross the blood brain barrier. First, we will 3H-radiolabel these
lead compounds and evaluate their specificity and concordance with neuroinflammatory markers in vitro. We will
subsequently develop 18F-radiolabeled ligands and assess their in vivo biodistribution and brain penetrance in
healthy C57/bl6 mice. The ability of these THIK-1 radiotracers to detect changes in microglial responses within
disease will be assessed in vitro and in vivo using animal models of Alzheimer’s disease and multiple sclerosis.
The specificity and sensitivity of these THIK-1 PET ligands for imaging microglia will be further assessed through
blocking and microglial depletion studies. The innovation of this multi-disciplinary proposal lies in the
development of the novel targeting of THIK-1 for highly specific and functionally relevant imaging of microglia.
This will be the first report of THIK-1-PET approaches. Additionally, PET imaging of THIK-1 will provide critical
information on the metabolism, efficacy, and safety of THIK-1 therapeutics. The novel approach proposed here
has high potential for significant impact in both fields of neuroinflammation and neurodegeneration research.
Enhancing understanding of the in vivo dynamics of microglia in neurological disease will improve disease
monitoring, screening of potential disease-modifying therapeutics, and development of effective strategies to
reduce risk of disease development.

Public health relevance
Project Narrative Microglia are key drivers in the pathogenesis of neurological and neurodegenerative disease. While advances in the understanding of microglial responses in vivo are essential to improve clinical diagnosis, disease monitoring/management, and screening of effective disease-modifying therapeutics, current approaches lack cellular and functional microglial-specificity. This work aims to develop and preclinically validate novel Tandem pore domain halothane-inhibited K+ channel 1 (THIK-1)-targeted PET radioligands as an innovative strategy to image microglial responses in vivo.